EFFECTS OF RECOMBINANT INTERFERON ON REPRODUCTION IN MACAQUES

Interferons (IFN) are a class of cytokines that are best known for their antiviral and immunomodulatory activities, but they also function in cellular differential, proliferation and more recently as hormones implicated in pregnancy during the periimplantation period in ruminant species. Since primate placentas have been shown to produce interferons and also contain receptors for such compounds, administration of such IFNs during fertile reproductive cycles could alter or disrupt early placental function or fetal development. We have initiated the second series of studies investigating the effects of two forms of recombinant human IFN (type 1a) on reproductive cycles, pregnancy and fetal development in rhesus macaques. These studies are in progress and results are not available.